Nanobody-based electrochemical biosensor for real-time detection of aerosolized SARS-CoV2

PROJECT SUMMARY
This supplement application is in response to the RADx-rad announcement on the opportunity of additional resources
and funding support to facilitate the pathway to commercialization. The opportunity was announced by RADx-rad Data
Coordination Center (DCC) and relayed then approved through the NIH SEED office.

Public health relevance
Project Narrative This study will collect aerosolized breath samples from participants seeking testing for SARS-CoV-2 and analyze them on a novel breathalyzer device developed at Washington University. The goal is assess specificity of the biosensor, as well as optimize the breathalyzer design for detection of aerosolized CoV-2 virus.